Modulating attention and decision making with closed loop control of low frequency oscillations

Project Summary
Synchronous low-frequency brain activity, as measured by human EEG, has been implicated in both normal
cognition and in disease states such schizophrenia. However, we still do not know whether changes in such
rhythms directly alter neuronal information processing, or are merely epiphenomenal. To address this issue, we
will measure how single and multi unit activity linked to task performance in non-human primates is altered by
endogenous alpha rhythms, and how that activity is changed when alpha rhythms are directly modulated via
closed-loop electrical stimulation. The proposal will offer a mechanistic explanation for the relationship between
alpha rhythms, attention, and perceptual decision making and validate the potential of direct modulation of alpha
rhythms as a therapeutic approach to attentional pathologies.

Public health relevance
Project Narrative Low frequency rhythms in human brain activity have been studied for 90 years and correlated with changes in attention, perception, and memory. However, it is still unknown if these rhythms actually change how the brain processes information, and, if they do, what these changes are. Here we propose to answer these questions by ﬁrst examining how endogenous rhythms alter the processing of visual information at the single cell and population level, and then by directly modulating these rhythms with electrical stimulation.